ISOLATION AND CHARACTERIZATION OF ENDOTHELIAL CELLS FROM NORMAL ORGANS AND TUMORS

The technical difficulties in obtaining primary microvascular endothelial cells in sufficient quantity has hampered in vitro studies on the advancement in understanding how cancer cells interact with vascular endothelium prior to extravasation. We have employed an immunomagnetic separation technique for obtaining pure primary cultures of endothelial cells. This involves the use of Dynabeads coated with either endothelial-cell specific antibodies or lectins. Monkey aortic endothelial cells were successfully separated and purified with immunobeads coated with Euonymus Europaeus Lectin (EEL). Positive identification of the endothelial cells was made by demonstrating the uptake of acetylated low density lipoprotein and electron microscopy. Presently, the major effort is on the isolation of lung and liver microvascular endothelial cells from a rat model, used in studies of tumor-endothelial cell interactions. Endothelial cell enrichment has been achieved with the use of a combination of Percoll gradient and lectin or antibody coated immunomagnetic beads on mixed cell populations from collagenase perfused rat livers. To improve the yield and purity of endothelial cells, the search goes on for a more specific antibody with a higher affinity for endothelial cell surface proteins. Immortalization of mixed cell populations, enriched with endothelial cells, followed by single cell cloning is an alternative means for obtaining pure endothelial cells for in vitro studies. Experiments have been started to immortalize endothelial cells through transfection with the E6/E7 transforming papil-loma genes, or the SV-40 large T antigen. The immunomagnetic bead approach is also being pursued for isolation of endothelial cells from primary tumors from the syngeneic rat metastasis model and hepatocellular carcinomas from nonhuman primates.